Single-cell spatial-temporal understanding of the role of macrophage subsets in maintenance of lesion biology and local Mycobacterium tuberculosis infection outcome

PROJECT SUMMARY/ABSTRACT
Lung macrophages serve as primary host cells for Mycobacterium tuberculosis (Mtb) during infection and are
recognized as one of the most crucial cell types in determining the outcome of Mtb infection. We have previously
reported that two types of lung macrophages, namely embryonic-derived alveolar macrophages (AMs) and
monocyte-derived interstitial macrophages (IMs), display different permissiveness to Mtb at the early stages of
infection in C57BL/6 mice. Such distinct permissiveness of macrophages to Mtb infection is determined by their
unique metabolic status. However, most of the studies performed to date on the interaction between lung
macrophages and Mtb have utilized in vitro models and/or primarily focused on the early stage of in vivo infection.
The widely used “resistant” C57BL/6 mice do not form caseous necrotic granulomas (lesions) that are a hallmark
of human tuberculosis (TB) disease, which additionally hinders the translation of our knowledge from the mouse
model to human disease. Further, while significant work has been put into understanding the immune drivers of
lesion formation, the role of immune cells in maintaining lesion structure and control of Mtb growth after lesions
have formed remains poorly understood. To this end, how different lung macrophage subsets differ in their
capacity to control or promote localized growth of Mtb, and how Mtb responds to the local environment in the
context of necrotic lesions during the later stages of infection, is almost completely unknown. Utilizing the
C3HeB/FeJ mouse Mtb infection model that forms the hallmark caseous necrotic lesions observed in human TB,
we have revealed that manipulation of different lung macrophage subsets after lesion formation has distinct
influence on Mtb growth in the necrotic lesions during the later stages of infection, depending on lesion
sublocation. We thus hypothesize that the function of lung macrophage subsets is spatially distinct and
contributes to the heterogeneity in local environment experienced by Mtb, and consequently bacterial
physiological status, within the lesions. We will test this hypothesis with two complementary aims. In Aim 1, we
will utilize novel metabolic analysis approaches together with spatial transcriptomics on the host side to elucidate
the role of AMs versus IMs in Mtb lesion biology in spatiotemporal context. In Aim 2, we will delineate the
relationship between macrophage subsets and local Mtb environment and activity at the single bacterium level,
adapting methods to visualize Mtb transcripts in situ. With both Aims, depletion of macrophage subsets, including
IMs, will enable elucidation of how macrophages act in the maintenance of lesion structure and local Mtb growth
control. Together, this work will provide a conceptual framework for understanding how permissiveness of lung
macrophage subsets relates to their spatial distribution within granulomas, and how this spatiotemporal
relationship impacts on local Mtb environment and growth.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB), caused by Mycobacterium tuberculosis (Mtb), is the leading cause of death from a single infectious agent. The lack of comprehensive understanding of the detailed interactions between lung macrophage subsets and Mtb in granulomas, a hallmark structure in human TB, significantly hinders the development of more effective antitubercular drugs. This proposal seeks to define the underlying mechanism of how different lung macrophage subsets determine the local environment that Mtb faces, ultimately controlling or promoting local growth of Mtb, in spatiotemporal context post-granuloma formation.